Novel AMPK activator for treatment of congenital X-linked nephrogenic diabetes insipidus in pediatric patients

PROJECT SUMMARY
NephroDI Therapeutics (NephroDI) is advancing a first-in-class therapeutic, NDI-5001, for treatment of
congenital X-linked nephrogenic diabetes insipidus (X-linked NDI). X-linked NDI is a rare pediatric orphan
disease characterized by the production of very large quantities of dilute urine due to mutations in the type 2
vasopressin receptor (V2R) that prevent activation of the cyclic adenosine monophosphate (cAMP)/protein
kinase A (PKA) signaling pathway. Individuals with X-linked NDI produce up to 20 L/d of dilute urine, almost 1
L/h 24-7-365. If left untreated, repeated episodes of severe dehydration may occur, eventually resulting in
serious complications including dehydration-induced cognitive impairment, and children are especially
vulnerable. The current therapeutic option for X-linked NDI patients is to drink as much water as they urinate and
severely limit dietary sodium (0.5 g/d) and solute intake. The unmet medical need in X-linked NDI is enormous.
Currently, there is no effective therapy for X-linked NDI.
NephroDI performed extensive efficacy, pharmacokinetic, formulation, and Investigational New Drug
(IND)-enabling toxicology studies, initially during the phase 1 STTR, and subsequently with venture capital and
a strategic partner. The nonclinical safety profile of NDI-5001 has been well characterized through the conduct
of secondary pharmacology and pharmacodynamic studies, in vitro and in vivo genetic toxicology, in vitro and in
vivo safety pharmacology, and pivotal 4-week repeat-dose toxicity and toxicokinetic (TK) studies in healthy rats
and dogs. The NDI-5001 IND-enabling toxicology studies were conducted under GLP and adhered to principles
set in place by the International Council on Harmonization (ICH). The NDI-5001 IND-enabling safety program is
considered adequate to support a first-in-human Single Ascending Dose (SAD), Food Effects, and Multiple
Ascending Dose (MAD) studies.
NephroDI’s business plan is to develop NDI-5001 for the treatment of X-linked NDI. NephroDI has been
granted Orphan Drug Designation (DRU-2022-9153) for NDI-5001 from the FDA. The goal of this phase 2 SBIR
application is to perform the additional, well-controlled, nonclinical studies necessary to support the pivotal
clinical study in pediatric subjects with X-linked NDI. NephroDI has the business infrastructure and domain
expertise to establish human proof of concept for NDI-5001, an investigational new drug for X-linked NDI. We
have a very strong IP position.
Specific Aim 1. GLP 39-week pivotal juvenile dog (pre-weaning) toxicology studies.
Specific Aim 2. GLP male-only rat fertility and early embryonic development (FEED) study.
Specific Aim 3. Develop a liquid formulation suitable for pediatric populations for use in clinical trials.
Completion of these Aims will enable NephroDI to proceed to the pivotal study, post-Phase 1, in pediatric
NDI subjects with documented V2R mutations.

Public health relevance
PROJECT NARRATIVE The goal of this project is to advance a therapy for a rare pediatric orphan disease, congenital X-linked nephrogenic diabetes insipidus (NDI), that currently lacks any effective therapy. X-linked NDI causes patients to produce a very large volume of dilute urine and can lead to severe dehydration. X-linked NDI is present from birth due to a mutation in the type 2 vasopressin receptor. Clinical symptoms present within the first few months of life. We will develop a novel drug treatment for patients suffering from X-linked NDI.